Administrative core

ABSTRACT: ADMINISTRATIVE CORE
The Personalized Medicine in Nevada COBRE's long-term goal is to establish itself as a nucleus to enhance
human genetics research, as well s the discovery and application of genetic and epigenetic amrkers. The
proposed COBRE builds upon existing strengths, seed funding from the Nevada Governor's office, and
collaboration with the newly accredited UNLV School of Medicine. During the COBRE phase I, we will establish
a research program in human genetics and informatics. The major goals are to (Aim 1) administer the program,
monitor progress, and iteratively improve the COBRE program; (Aim 2) mentor new investigators to become
independent; (Aim 3) expand the human genetics infrastructure at UNLV, in Nevada, and in the IDeA Network;
and (Aim 4) cultivate a pipeline of new independent investigators for personalized medicine research. The new
investigators and pilot grant awardees will be supported by two research cores centered on genomics and
bioinformatics, and a mentoring plan based upon best practices and preliminary studies. The new Genome
Analysis and Sequencing Pipeline (GASP) and the Human Genome Data Algorithms to Analytics (HuGe DAtA)
Cores, leverage UNLV and local infrastructure
The Administrative Core (AC) will be run by PI, Martin Schiller and Co-PI, Xiangning Chen. The external and
internal advisory committees, along with consultants will help guide them on COBRE program decisions. The
AC will have an oversight role over two research cores, three new investigator research projects, a pilot grant
program, and a mentoring panel. The main responsibilities for the Administrative Core are: providing
leadership, governance of the COBRE, fiscal management, promoting interactions among institute participants
and with external organizations, assessing performance, reporting to NIH, program oversight, and organization
of mentoring activities. The AC will work with an independent Program Assessor to monitor progress toward
key milestones and benchmarks for the program, and use this information in consultation with the external
advisory boards for cycles of improvement each year. Some of the innovative aspects of this proposal are: (1)
the COBRE research theme on discovery and application of genetic and epigenetic markers for personalize
medicine; (2) having new investigators review grants for Grant Club and the CTR-IN Advance to Funding
program; (3) the GASP Core supporting the use and ensure quality of other core services; and (4) a novel
assessment approach using graph analytics as a surrogate for measuring culture.

Public health relevance
PROJECT NARRATIVE: ADMINISTRATIVE CORE The Personalized Medicine in Nevada COBRE program seeks to build a sustained interdisciplinary center in personalized medicine by engaging local partners, building genomics and big data analysis infrastructure, and conducting human genetics research. The institute will create an environment that cultivates the career development of new investigators, increases our understanding of personalized medicine, and provides a foundation upon which the new UNLV Medical School and other health care organization can grow clinical genetics research, education, and medical genetic services in Nevada.